Mechanisms and consequences of programmed cell death (apoptosis) and compensatory proliferation in Drosophila

Mechanisms and Consequences of Apoptosis and Apoptosis-induced
Proliferation in Drosophila
Principal Investigator: Andreas Bergmann, Ph.D.
University of Massachusetts Medical School, Worcester, MA
Apoptosis is the major form of cell death that is critical for normal development and tissue
homeostasis of multi-cellular organisms. Defects in the regulation of apoptosis contribute to the
pathogenesis of multiple diseases including those associated with reduced rates of cell death
(cancer, autoimmunity) or with excessive cell death (neurodegeneration, stroke, myocardial
infarction). Apoptotic cells interact with and influence the behavior of their cellular environment
by releasing anti-inflammatory, pro- and anti-apoptotic as well as mitogenic signals. The release
of the latter triggers Apoptosis-induced Proliferation (AiP) which describes the ability of
apoptotic cells to induce regenerative proliferation of neighboring surviving cells, thus
compensating for their loss. Unexpectedly, evidence obtained in several organisms including
Drosophila, Xenopus, Hydra, Mouse and human cancer suggests that regenerative AiP of
amputated or otherwise damaged tissues including tumors depends on apoptotic caspases
(highly specific cell death proteases) in addition to, but independently of, their apoptotic function.
The overall objective of this scientific program is to gain a comprehensive
understanding of the biological principles that underlie the regulation of apoptosis and AiP in a
multi-cellular organism, to identify and characterize the genes involved in these processes, and
to develop methods to manipulate them. We are using the powerful genetic model organism
Drosophila melanogaster for these studies. We have developed genetic models of apoptosis
and AiP, and initiated forward genetic screens that directly assessed the genetic basis of these
fundamental processes. This application focuses on four key questions. 1. How is the fine-tuning
of caspase activity achieved? 2. What are the proteolytic targets of caspases for non-apoptotic
functions? 3. How do caspases control the generation of reactive oxygen species (ROS) for AiP?
4. How do macrophages (hemocytes) adopt an activated phenotype for growth control?
This program is very relevant for understanding of human cancer. Our studies elucidate
mechanisms by which potential tumor cells increase their resistance to apoptosis, a hallmark of
cancer, which may generate immortalized (undead) cells. Moreover, apoptotic tumor cells
promote caspase-dependent AiP. For example, although radio- and chemotherapy attempt to
cure cancer by killing tumor cells, relapse of treated tumors is frequently observed which may
be due to an AiP-promoting activity of dying tumor cells. Therefore, the results of this research
program will significantly improve our understanding of apoptosis and regenerative
proliferation under normal conditions, and tumor phenotypes under pathological conditions.

Public health relevance
Project Narrative The scientific program of the principal investigator includes an investigation of the genes and mechanisms that control apoptosis and that initiate regenerative responses after massive stress- or injury induced apoptosis in multi-cellular organisms. Understanding the mechanisms of these processes may lead to new therapeutic interventions for cancer and regeneration.